Identifying and predicting subgroups related to function in individuals after stroke.

PROJECT SUMMARY/ABSTRACT
Two common, long-lasting deficits after stroke are impaired mobility and cognition. Impairments in mobility and
cognition are associated with numerous negative health consequences, including falls, poor quality of life, and
hospital readmissions. Recovery of mobility and cognition after stroke is highly variable and poorly understood.
Therefore, rehabilitation professionals are unable to provide interventions that are tailored to each specific
patients they treat, contributing to a “one size fits all” approach to post stroke rehabilitation that is characterized
by incomplete recovery and high healthcare costs. A comprehensive characterization of recovery and models
that predict recovery are essential to shifting towards interventions that are tailored to specific individuals after
stroke. Thus, the overall objective of this proposal is to develop models that predict what recovery trajectory of
mobility and cognition individuals after stroke will follow. Recovery trajectories completely describe patient
recovery and are characterized both their extent (i.e., large, moderate, or limited) and temporal pattern (i.e.,
fast or slow). Both the extent and pattern of recovery can impact the type, timing, and dosing of rehabilitation
interventions; however, the extent of recovery has been the focus of previous work. Models that predict the
recovery trajectory, rather than just the extent of recovery, for mobility and cognition for individuals after stroke
are essential to moving towards rehabilitation interventions that are targeted towards specific individuals after
stroke. Past work related to upper extremity recovery after stroke suggest that there are subgroups related to
recovery trajectories and that the characteristics of individuals can be used to develop predictive models.
Therefore, the central hypothesis of this work is that we can 1) characterize recovery trajectories for mobility
and cognition after stroke and 2) use characteristics of individuals after stroke to develop models to predict
mobility and cognition recovery trajectories. The results of this proposal will provide a comprehensive
understanding of the recovery of mobility and cognition after stroke and an accurate predictive model of the
recovery trajectories of mobility and cognition. This will guide the development and delivery of interventions to
the right person at the right time to optimize functional recovery and improve the efficiency of our healthcare
system. Additionally, the proposed work serves as a first step towards the long-term goal of this fellowship
applicant, which is to understand variability in patient recovery in order to move post-stroke rehabilitation
towards the delivery of interventions that are tailored to each specific patient, thereby, improving patient
outcomes within a more efficient healthcare system. By completing this fellowship proposal under the guidance
of experienced mentors in a strong research environment, the applicant will receive the training needed to
become a productive, independent scientist and to achieve her long term career goals.

Public health relevance
PROJECT NARRATIVE The extent and pattern of recovery related to mobility and cognition after stroke is highly variable and poorly understood, which limits the ability of rehabilitation professionals to provide targeted clinical care. This project aims to understand this variability in post stroke recovery by 1) identifying subgroups of recovery trajectories, characterized by the extent and pattern of recovery, related to mobility and cognition and 2) predicting what recovery trajectory individuals after stroke are likely to follow. The results of this study will improve our understanding of post stroke recovery, allow for the development, testing, and implementation of targeted rehabilitation interventions, and move post stroke rehabilitation towards precise prescription of rehabilitation interventions.